Angiogenin and plexin-B2 in therapeutic resistance and disease relapse of GBM

PROJECT SUMMARY
Glioblastoma (GBM) is a fatal disease. The standard of care of GBM has not changed over decades. Tumor
recurrence occurs universally and the recurred GBM lacks effective therapeutics. Glioma stem cells (GSCs),
which are resistant to radio- and chemo-therapy, are a major cause of GBM recurrence. Identification and
characterization of regulators and pathways that maintain the stemness properties of GSCs will help reveal new
targets to eliminate, diminish, or exhaust GSCs to overcome therapeutic resistance and to prevent disease
recurrence. We have discovered that angiogenin (ANG), a secreted ribonuclease, and its functional receptor
plexin-B2 (PLXNB2), a single pass transmembrane protein, constitute a ligand-receptor pair that enhances the
stemness of patient-derived GSCs by promoting small RNA biogenesis, in particular, the production of tRNA-
derived stress-induced small RNAs (tiRNAs), and primarily the 5’tiRNAGly-GCC. PLXNB2 inhibition, by either gene
knockout or specific monoclonal antibodies (mAbs), reduces the self-renewal ability and diminishes the
tumorigenic capacity of patient-derived GSCs. A combinatorial treatment with PLXNB2 mAbs and temozolomide
(TMZ) delayed the recurrence of GSC-drived orthotopic GBM and prolonged animal survival as compared to
TMZ monotherapy. PLXNB2 mAb therapy was found to reduce the intra-tumor level of tiRNAs including
5’tiRNAGly-GCC. There was an inverse correlation between the 5’tiRNAGly-GCC level in the tumor and animal survival.
We therefore propose to characterize the ANG-PLXNB2-tiRNA axis as a novel regulatory pathway that maintains
the stemness properties of GSCs and that can be targeted to prevent or delay GBM recurrence upon chemo-
and radio-therapy. Specific aim 1 is to characterize the function of the ANG/PLXNB2 axis in regulation of GSC
properties and GBM recurrence. We will 1) examine the role of ANG/PLXNB2 in proneural type and
mesenchymal type GSCs to understand if the regulatory function is limited to a specific GSC type or if it is more
broadly applicable; 2) differentiate the function of ANG and semaphorin 4C, the other high affinity ligand of
PLXNB2, in GSCs. Specific aim 2 is to elucidate the mechanism by which ANG/PLXNB2 regulates GSC
stemness and GBM recurrence. We will 1) examine the function and mechanism of 5’tiRNAGly-GCC in regulating
GSC stemness and GBM chemoresistance; 2) examine the functions of other tiRNA species that are significantly
regulated by ANG/PLXNB2; 3) conduct proteomics studies to identify tiRNA-regulated proteins, and characterize
how they mediate GSC stemness and chemoresistance. We expect that we will be able to demonstrate ANG
and PLXNB2 as novel GSC regulators, characterize the molecular mechanism by which they maintain GBM
stemness, and establish ANG-PLXNB2-tiRNA axis as a targetable pathway for the purpose of preventing GBM
recurrence upon radio- and chemo-therapy.

Public health relevance
PROJECT NARRATIVE We have shown that angiogenin and its receptor plexin-B2 are a novel pair of regulators of GSC stemness. The objective of this proposal is to understand the mechanism and function of angiogenin-modulated small RNA in regulating self-renewal and tumor-initiation capacity of GSCs, and to assess therapeutic activities of plexin-B2 monoclonal antibodies to attenuate GSC stemenss and to delay GBM relapse upon chemo- and radiotherapy.